Characterizing the structure and function of a viral RNA element in inhibiting an antiviral protein

PROJECT SUMMARY
RNA viruses are a constant threat to global health and understanding their interactions with host cells at the
molecular level is necessary for identifying therapeutic targets. Viruses contain diverse types of structured RNA
elements within their genomes with a variety of functions that are critical for successful infection. One such
structured RNA element was identified within poliovirus and protects the genomic RNA from degradation by the
mammalian endonuclease, ribonuclease L (RNase L). This RNA was found to be a competitive inhibitor of RNase
L, preventing degradation of viral genomic RNA. Previous experiments have confirmed the secondary structure
of the poliovirus competitive inhibitor RNA (ciRNA) as well as key tertiary contacts required for inhibition function;
however, the 3D structure of the poliovirus ciRNA and its specific intermolecular interactions with RNase L that
enable inhibition remain unresolved. Additionally, the ciRNA element was identified in the poliovirus genome but
its presence in divergent RNA viruses has not been explored or classified. I hypothesize the ciRNA structure
directly inhibits RNase L by physically blocking its active site. The ciRNA relies on crucial secondary
and tertiary contacts to maintain its inhibitory properties. I will identify ciRNA elements in additional viral
genomes and define the phylogenetic distribution of this class of RNAs. To test these hypotheses, I will
use a combination of biophysical techniques, structural biology, biochemical assays, and bioinformatics. Aim 1.
I will use a bioinformatic approach to query a viral genomic database for ciRNA elements and test new putative
hits for RNase L inhibition activity using a fluorescence-based assay. I will use biochemical methods to map the
binding site of RNase L on ciRNA to find the conserved binding site among all examples. Aim 2. I will characterize
the interaction between the ciRNA and RNase L (and their mutants) using microscale thermophoresis to quantify
the binding affinity and measure the stoichiometry between these two molecules and biochemically relevant
mutants. To fully characterize this interaction on a molecular level, I will use cryo-electron microscopy to solve
the structure of the ciRNA-RNase L complex. The work outlined in this proposal will provide insight into how
structured RNA elements directly interact with host protein factors, and how these have evolved in the viral world.

Public health relevance
PROJECT NARRATIVE RNA viruses pose one of the biggest threats to human health and generalized therapeutics are needed. This project will investigate a class of structured viral RNA elements first identified in poliovirus that inhibit a critical host immune response pathway. These studies are essential to understand the interplay between viral genomes and their hosts, laying the foundation for the development of potential therapeutics.